Assessing early-life exposure to replacement flame retardant chemicals and associations with thyroid disruption and altered neurobehavioral function in a longitudinal birth cohort

PROJECT SUMMARY
Flammability requirements are set for consumer products by state and federal agencies, resulting in the addition
of flame retardant chemicals to furniture, textiles, electronics, and other products found ubiquitously in homes
around the world. The production volumes of organophosphate flame retardants (OPES) have drastically
increased in recent years due to the phase-out of the neurotoxic polybrominated diphenyl ether (PBDE) flame
retardant chemicals. The metabolites of OPES are detectable in biological samples of 77-90% of U.S. adults,
and exposure occurs mainly through accidental dust ingestion. There is a startling lack of research into the health
consequences of exposure to these replacement flame retardants, but they have been linked to neurobehavioral
toxicity and thyroid hormone disruption in animals. Tight thyroid hormone regulation during gestation and early
childhood is essential for normal brain development, and others have speculated that thyroid disruption may be
one mechanism by which OPEs cause neurotoxicity. There is very little research on the consequences of OPE
exposure in humans, and none in children or longitudinal cohorts. We intend to fill this knowledge gap with the
proposed work. Our overarching hypothesis is that exposure to OPEs during gestation and early childhood is
associated with thyroid hormone disruption, decreased child intelligence, and increased ADHD behaviors. In aim
1, we will measure the association between exposure to OPEs at several time points and thyroid function in
children. In aim 2, we will investigate the link between OPE exposure and child intelligence and ADHD symptoms,
including a mediation analysis to determine whether thyroid function lies on this causal pathway. Finally, aim 3
will involve a mixtures analysis of exposure to a combination of OPEs, PBDEs, and lead and the outcome of
child intelligence. To accomplish these aims, we will utilize a well-established prospective pregnancy and birth
cohort in the Greater Cincinnati area—the HOME Study (n=410 births with follow-up to 12 years of age). We
will analyze stored household dust and urine samples from pregnant women and their children to measure
exposure to OPEs at up to nine time-points. We will also examine previously measured thyroid hormone levels
from maternal blood, cord blood, and child blood and draw on an extensive battery of child neurobehavioral data.
For the chemical mixtures analysis, serum PBDE concentrations and blood lead levels have already been
measured from maternal and child samples, and we will employ five different analytical methods to explore
synergistic interactions and joint effects on the outcome of child intelligence. This project will be the among the
first to systematically explore the relationship between pre- and post-natal replacement flame retardant
exposure, TH levels, and neurobehavior in an established birth cohort of children. The results of our chemical
mixtures analysis will give this field additional context and relevance to real-world settings. Our findings will help
inform public health policy around flame retardant chemicals and could help guide environmental health
educational goals for communities.

Public health relevance
PROJECT NARRATIVE Exposure to a new type of flame retardant chemicals is increasing in the United States despite concerns that these chemicals may change hormone levels and brain function in humans. We will observe how children exposed to various levels of flame retardant chemicals may have different thyroid hormone levels, intelligence, and ADHD behaviors. We will also investigate how being exposed to mixtures of chemicals like old flame retardants, new flame retardants, and lead may have different effects on human health outcomes than exposure to single chemicals alone.